Developmental and genetic mechanisms of diversity and disease

PROJECT SUMMARY
Understanding the molecular basis of anatomical variation is a fundamental challenge in biology. In
some cases, the genes that control anatomical defects in humans underlie normal variation in other species;
therefore, a comprehensive understanding of the general molecular mechanisms of diversity promises a
greater understanding of human health. I have pioneered molecular developmental and genetic studies of
domestic pigeons as a model for dramatic anatomical variation. In just a few years, we have made rapid
progress to discover the molecular underpinnings of complex traits in pigeons, including the discovery that
genes underlying hereditary disease and cancer in humans also play key roles in animal diversity.
This project seeks to deepen and broader our understanding of the molecular basis of typical and
abnormal variation. The pigeon is an ideal system in which to pursue these goals because it features
tremendous morphological variation within a single species, thereby facilitating genome-wide association
studies, traditional genetic mapping, and functional developmental biology. First, we will identify the regulatory
mechanisms that control forelimb and hindlimb identity. In certain breeds of domestic pigeon, our genetic
mapping and developmental studies show that regulatory changes in two genes are associated with the
replacement of scales by feathers on the feet. In humans, mutations in these same genes cause striking limb
malformations. We will identify specific mutations causing regulatory changes in pigeons by testing enhancer
constructs in ovo, and use high-throughput RNA sequencing to identity the downstream gene regulatory
networks that control limb identity. Second, we will map the genes controlling major changes in craniofacial
size and shape through genome-wide association scans and genetic mapping in laboratory crosses. We will
use functional testing of candidate genes and transcriptome profiling to identify the molecular basis of radical
variation in beak structures. The craniofacial skeleton of pigeons shows spectacular variation among breeds,
and abnormal development of these same structures accounts for one-third of human birth defects. Therefore,
understanding the molecular basis of this variation is critical to understanding of both natural variation and
pathogenesis of human craniofacial disorders. Third, two classical pigeon mutants exhibit variation in both
pigmentation and eye development. Phenomenological links are well established between pigment variation
and eye development, but mechanistic links are often ambiguous. We have identified strong candidate genes
for both mutants, and will use pigeons and other canonical model organisms to functionally test the impact of
their altered expression.
Together, these complementary genetic, genomic, and developmental approaches will identify the
molecular basis of astonishing variation in an innovative model system, thereby opening new avenues to
understand the conserved roles of specific genes in normal and disease variation among vertebrates.

Public health relevance
PROJECT NARRATIVE In humans and other animals, normal anatomical diversity and birth defects often result from changes in DNA sequences. To better understand how normal and abnormal variation is regulated, we are studying the spectacular variation among domestic pigeons, which show extreme variation in skin structures (feathers or scales), beak size and shape, and links between pigment variation and eye defects. The proposed research will discover how certain genes and mutations affect critical aspects of embryological development, including limb development, facial development, and how certain genes simultaneously affect hereditary blindness and the color of skin structures.